Control of the MYC Super-Enhancer Complex in FLT3-ITD Acute Myeloid Leukemia

PROJECT SUMMARY/ABSTRACT
Acute myeloid leukemia (AML) is an aggressive blood cancer with a 5-year expected survival rate of less
than 30%. Internal tandem duplications (ITD) of Fms-like tyrosine kinase 3 (FLT3) is a common mutation in AML
and is a molecular driver of immature blood cell proliferation. Despite advances in the development of FLT3
kinase inhibitors, remissions are short-lived. I have previously shown that inhibition of the epigenetic regulator
lysine-specific demethylase 1 (LSD1) enhances the efficacy of FLT3 inhibitors in FLT3-ITD AML. The drug
combination induces leukemic cell death by disrupting regulatory binding at the MYC blood-specific super-
enhancer complex (BENC), resulting in a loss of activity and expression of the MYC proto-oncoprotein. In Aim
1, I will use single cell chromatin accessibility sequencing and high-resolution epigenetic profiling of primary AML
samples to define the transcription factor regulators of the MYC BENC in FLT3-ITD AML. In Aim 2, I will use
activating CRISPR technology and drug sensitivity assays to identify the individual MYC BENC enhancer
modules that are critical for the activity of combined FLT3 and LSD1 inhibition. Successful completion of these
studies will determine the molecular control of the MYC BENC in FLT3-ITD AML, nominating novel targets and
enabling personalization of dual FLT3 and LSD1 inhibition for patients with FLT3-ITD AML.
My goal is to manage an independent systems biology research group that investigates molecular
leukemia biology and targeted leukemia therapies while simultaneously practicing as a hematologist oncologist
at an academic research institute. This application proposes a comprehensive and interdisciplinary training plan
within a prominent academic medical and research institution that seamlessly integrates with the research
proposal and provides essential training in computational and molecular cancer biology. I will receive guidance
in drug sensitivity and functional genetic techniques as well as access to one of the largest AML patient
biorepositories in the world from my sponsor, Dr. Brian Druker, a pioneer in the field of targeted leukemia therapy
and Director of the Knight Cancer Institute. I will be supported in analysis of single cell sequencing data from my
co-sponsor, Dr. Emek Demir, the Section Head of Computational Biology at the Knight Cancer Institute. I will
learn to apply high-resolution epigenetic profiling techniques to investigate epigenetic regulatory mechanisms in
leukemia from my co-sponsor, Dr. Theodore Braun, a physician-scientist and Assistant Professor of Hematology
& Medical Oncology. I will be trained in the use of single cell chromatin accessibility sequencing from a leader in
single cell sequencing technologies, Dr. Andrew Adey. I will learn to use integrative systems biology techniques
to study targeted leukemia therapies from my thesis advisory committee member, Dr. Laura Heiser. I will learn
to design and test my hypotheses in the context of therapeutic responses in cancer from my thesis advisory
member, Dr. Naoki Oshimori.

Public health relevance
PROJECT NARRATIVE Internal tandem duplications (ITD) of Fms-like tyrosine kinase 3 (FLT3) is a common driver mutation of acute myeloid leukemia (AML) and confers a poor prognosis for patients with AML, yet inhibitors of FLT3-ITD signaling are rarely curative. The proposed research will utilize single cell chromatin accessibility sequencing, high- resolution epigenetic profiling, functional genetic technologies, and drug sensitivity assays to investigate the epigenetic regulators of the MYC proto-oncogene, a key downstream target of FLT3-ITD signaling that enables uncontrolled leukemic proliferation, at the MYC blood-specific super-enhancer complex. Determination and validation of the regulatory factors of the MYC super-enhancer complex in FLT3-ITD AML will contribute to our understanding of leukemogenesis with the potential to uncover therapeutic targets aimed at the molecular mediators of FLT-ITD signaling.